PROSTATE CANCER--A DECISION-AID VIDEO FOR PATIENTS

DESCRIPTION: The goal of this Phase II proposal is to produce and test a videotape about treatment options for prostate cancer that presents medically rigorous information in nontechnical language using documentaries of real patients. The videotape will be designed as a decision-aid to promote informed decision-making about treatment as well as to increase patient satisfaction with their decisions. During Phase I, a script for one segment of the video and a very good seven-minute video excerpt were developed based on feedback from men treated for prostate cancer, their partners, urologists and nurses. PROPOSED COMMERCIAL APPLICATION: Not available.